Expanding and Enhancing Scientific Instrumentation Prototyping and Fabrication at The Rockefeller University

ABSTRACT
The proposed project involves focused construction to expand the advanced fabrication facility and
capabilities at The Rockefeller University in Manhattan, New York City. The Precision Instrumentation
Technologies (PIT) Resource Center provides a centralized and expertly staffed prototyping and fabrication
facility that supports more than 50 principal investigators at The Rockefeller University (RU). This project seeks
to expand and enhance our design and fabrication capabilities. The project goals are to: (1) Renovate and
annex adjacent space to the current PIT to accommodate additional instrumentation, activities, and personnel;
(2) Undertake elevator removal and rigging required to add institutionally funded fabrication equipment (CNC
mill, CNC lathe, water jet cutter); and (3) Create a new microfabrication facility.